Brainstem Contributions to Sensorimotor and Core Symptoms in Children with Autism Spectrum Disorder

PROJECT SUMMARY/ABSTRACT
The brainstem is a complex and early-developing brain region that is responsible for sensory, motor,
autonomic, and critical-for-life functions. The first biology-based hypothesis of autism suggested that the
brainstem's reticular formation was responsible for the behavioral features of autism. However, technological
barriers have prevented the field from reliably characterizing brainstem substructures in vivo. Excitingly,
recent technological advances now allow us to examine the microstructural properties of the brainstem's
individual nuclei and white matter tracts using Magnetic Resonance Imaging. In our original R01, our group
contributed to these technological advances through innovative development and refinement of acquisition
and post-processing techniques that optimize brainstem imaging. We applied these techniques in autistic
children to show how brainstem substructures relate to sensorimotor and core diagnostic features. Yet, the
brainstem is highly connected, and we still do not know how the brainstem contributes to autistic whole-brain
networks. Leveraging the findings of the original R01, the overall scientific premise of this renewal is that
brainstem substructures, as key hubs in whole-brain networks, may hold significant insights into the
neurobiological underpinnings of primary and secondary features of autism. Given the functions of the
brainstem, we hypothesize that the whole-brain connections of key brainstem nuclei will explain variation in
sensorimotor, autonomic, feeding, and core autism features. This hypothesis will be tested through two
specific aims: 1) Determine brainstem-inclusive whole-brain network differences and markers of social and
repetitive behavior features in autistic children compared to non-autistic children. 2) Identify brainstem-
inclusive network associations with sensorimotor and autonomic features in autistic and non-autistic children.
We will perform brainstem-inclusive whole-brain tractography across three datasets: 1) our original R01's
data of brainstem-optimized imaging and measures of sensorimotor and autistic features in 74 autistic and
74 non-autistic children; 2) a new dataset with further brainstem-imaging improvements, feeding, and
respiratory sinus arrhythmia measures in 74 autistic and 74 non-autistic children/youth; and 3) publicly
available core diagnostic and neuroimaging data to which we will apply brainstem-optimized processing. An
innovative Mahalanobis Distance measure and graph theory measures will quantify group and individual
differences in brainstem-inclusive networks. Successful completion of this research will provide a quantitative
characterization of brainstem-inclusive whole-brain networks that will advance the understanding of the
neurobiological basis for core and co-occurring autism features. These contributions will be significant by
paving the way for determining age-appropriate and biology-informed interventions for the prevalent
sensorimotor, feeding, and cardiorespiratory differences of autistic individuals.

Public health relevance
PROJECT NARRATIVE The prevalence and impact of autism are widely known, but the brain basis of autism remains unclear, particularly in the understudied region of the brainstem. The proposed research will solve an urgent public health need to provide a more complete depiction of brainstem-inclusive, whole-brain networks in reference to the core, sensorimotor, and autonomic features prevalent in autistic children. In line with the NICHD and IACC's priorities and with the NIH's mission, the proposed work will help promote health and well-being through improved knowledge of the neurobiological basis of the core diagnostic and co-occurring features of autism, enabling the development of biologically informed interventions.